Molecular and functional investigation of the role of HLA-F in immune regulation

Project Summary/Abstract
HLA-F is a nonclassical class I MHC (Ib) molecule that has been found expressed on a variety of cancers,
shown to play a role in HIV and adenoviral infection, the neurological autoimmune disease ALS and is expressed
throughout pregnancy. Despite the potential importance of this protein in these conditions, little is known about
this molecule in terms of its function or even in which conformational state it is expressed. We have recently
shown that, in addition to being expressed as a heavy chain only state, or open conformer (HLA-FOC), HLA-F
can also be expressed as a bon fide peptide presenting molecule, associated with the β2m subunit (pHLA-F).
Peptides are presented in an unconventional way, with the N-terminus not anchored within the groove and the
potential for post-translational modifications featuring in peptide anchoring. Despite these advances, there
remains much unknown about how these conformer states are regulated, how it engages its various receptors
in each of these conformer states, and the role of HLA-F in its various environments of tumor surveillance,
autoimmunity and reproduction. Thus, the aims of this proposal focus on addressing these questions and are:
Aim 1: To investigate, structurally and functionally, the various conformer states that HLA-F adopts in
human health and disease. We will pursue structural studies of the HLA-F isoforms to understand how these
two states differ from each other. Using conformer-specific antibodies, we will determine what cell types express
which (or both) forms and how this differs between healthy and disease cells. We will also pursue peptide elution
studies from a range of human sources to determine if the peptide repertoire shifts depending on cellular origin
or disease. Aim 2: To identify and analyze the factors that regulate the production or interchange of HLA-
F conformers and splice forms in a cell. We will explore the cellular factors that may play a role in switching
HLA-F between peptide-loaded and HLA-FOC as well as an intriguing splice variant of HLA-F of unknown function.
Finally, in Aim 3 we seek to establish the receptor repertoire that engage HLA-F in its various conformer
states, determine the molecular basis for their association and study the functional consequences of
their binding. We will employ the structural, biophysical and functional expertise of the Adams lab to determine
the receptor repertoire that engage these conformer states of HLA-F and study them at the functional and
molecular level.

Public health relevance
Project Narrative HLA-F is a nonclassical MHC class I molecule that likely plays a role in cancer, HIV infection, autoimmunity and reproduction. It was previously thought to exist only as a heavy chain, without association with the 2microglobulin (2m) subunit or bound peptide. We have recently shown that HLA-F can associate with both 2m and peptide, these two states of HLA-F confer differing reactivity to receptors expressed on effector cells. The goal of this proposal is to understand, at the molecular and functional levels, how HLA-F engages with these receptors.